Gram-positive secretion chaperone-client interactions

Project Summary
Our research program focuses on post-translocation secretion chaperones in Gram-positive bacteria, so as
to better understand the processes underlying protein secretion, activity, and regulation following membrane
translocation. Currently, little is known about post-translocation protein folding in Gram-positive bacteria which
presents a barrier to understanding the core biology of these organisms and how they interact with their
environment. We hypothesize that Gram-positive secretion chaperones regulate proper folding, stabilization,
and activity of secreted proteins that contribute to bacterial physiology. We use two model organisms, Listeria
monocytogenes and Streptococcus pneumoniae as tools to determine secretion chaperone activities and
mechanisms that are both broadly conserved and species-specific. Gram-positive bacteria encode secretion
chaperones that belong to two distinct peptidyl-prolyl isomerases (PPIases) families which include PrsA
homologs from the parvulin PPIases and SlrA homologs from the cyclophilin PPIases. Over the next 5 years,
we will identify and characterize these secretion chaperone-client repertoires, identify chaperone domains
critical for client interactions, and elucidate molecular mechanisms of chaperone-client interactions and
regulation. We anticipate that the goals proposed in this grant will have broad relevance to several Gram-
positive post-translocation secretion mechanisms. Therefore, by defining paradigms of Gram-positive secretion
chaperone-client activation and regulation, we will provide novel insight into the molecular mechanisms
governing the core biology of these fascinating organisms.

Public health relevance
Project Narrative Gram-positive bacteria are highly adaptable organisms that interact with their environment to acquire nutrients, mitigate high stress conditions, and establish replication niches. A fundamental aspect of Gram- positive biology is the ability to secrete proteins that provide structural and enzymatic functions which facilitates adaptation to environmental changes. This research is focused on Gram-positive secretion chaperones so as to better understand the processes underlying protein secretion, activity and regulation following membrane translocation.